QUANTITATIVE ASSESSMENT--VISUAL FUNCTION-SCHIZOPHRENIA

Recent psychophysical studies indicate that schizophrenic patients, compared to normal controls, have enhanced sensitivity to certain percisely defined visual stimuli and decreased sensitivity to other stimuli. This intriguing pattern of stimulus dependent superior and inferior performance is similar to effects produced in normal subjects after the administration of 1-dopa. The inverse pattern is seen after acute haloperidol administration in psychotic patients and in Parkinson's patients. The few reports of these effects in schizophrenic patients have failed to control adequately for medication status and clinical state, although these are clearly issues of significant concern. We propose to assess visual function in neuroleptic responsive and non-responsive patients, both on and off medication, in order to clarify the role of dopaminergic elements of the visual system in producing these effects. Visual function will be quantitatively assessed in two samples of schizophrenics, 10 who show significant improvement with neuroleptic treatment and 10 who are nonresponsive to treatment, and in 10 normal controls. Controls will be tested drug free and after an acute test dose (5 mg PO) of haloperidol. Patients will be tested immediately prior to drug discontinuation (in non-responders), 14 days drug free, at the end of washout, acutely after 5 mg PO haloperidol and during the 5th week of a prospective haloperidol treatment phase. The amplitude and phase of evoked responses to 16 visual stimuli (4 spatial frequencies 4 temporal frequencies) will be measured at 18 locations on the scalp. The two cerebral hemispheres will be independently stimulated at 4 cpd and 4 Hz in order to assess the lateralization of tuning. The contrast sensitivity threshold will also be determined psychophysically. The study will address the role of dopaminergic elements of the visual system in schizophrenia and the acute and chronic effects of haloperidol on these systems. While we are aware of one report of visual abnormalities of the sort we anticipate in an undifferentiated population of schizophrenics, this will be, to our knowledge, the first study to specifically address the role of dopaminergic visual mechanisms in schizophrenia.